Enrichment Program

PROJECT SUMMARY – ENRICHMENT PROGRAM
The Enrichment Program provides opportunities for education and networking for the Liver Center in four related
ways. First, the Program provides Center members with the latest information about their specific areas of
interest. Second, the Program seeks to broaden the appreciation that Center members have for related areas of
research in liver biology and pathobiology. Third, the Program seeks to enhance collaboration among Center
members; in part because of the enrichment program, nearly all Center members collaborate with at least one
other Center member and half of all Center-related publications are co-authored by multiple Center members.
Finally, the Program serves as an outreach mechanism to non-liver physicians, scientists and lay people to
enhance their understanding of liver disease. We have established several mechanisms to achieve these goals.
These include (1) a monthly seminar series, (2) an annual retreat, (3) a quarterly newsletter, (4) certain special
scientific and educational programs and symposia, (5) an annual visiting professorship program “reverse mini-
sabbatical”, and (6) a website. All Center seminars, conferences, symposia, and newsletters are posted on the
Center’s website, which is updated weekly, and advertised via poster and e-mail notification. Through these
activities, the Enrichment Program creates opportunities for open discussions of the latest developments in the
fields of liver pathophysiology and treatment. The Enrichment Program fosters collaborations, publications and
grants by bringing leaders in the most advanced areas of hepatology research to Yale. This represents a
particularly valuable opportunity for junior investigators to develop networking, establish relevant collaborations,
and obtain access to important and unique reagents and technologies.